Xenobiotic Receptors in Mediating the Environmental Effects on Human Disease and Morbidity

Title: Xenobiotic Receptors in Mediating the Environmental Effects on Human Disease and Morbidity
Project Summary/Abstract:
This R35 proposal is designed to consolidate our current NIEHS funded projects into one program with the
focus on understanding the role of xenobiotic receptors in regulating the metabolism of xenobiotics and
endobiotics and the implications of this regulation in human health. The human population is at an increasing
risk of developing chronic diseases, such as fibrosis, metabolic syndrome, alcoholic liver disease, and
neurologic disorders. Environmental factors, including environmental chemicals, are among the major
contributing factors in the pathogenesis of these chronic diseases. As such, understanding the mechanisms
by which environmental chemicals modify human physiology and pathophysiology will help to design
therapeutic or preventive strategies to mitigate the pathogenic effect of environmental chemicals. Xenobiotic
receptors, including the xenobiotic nuclear receptors pregnane X receptor (PXR) and constitutive androstane
receptor (CAR) and the PAS domain transcriptional factor aryl hydrocarbon receptor (AHR), are best known for
their functions in sensing xenobiotic chemicals and regulating xenobiotic metabolism. Emerging evidence,
mainly through the creation and characterization of gene knockout mice and identification of endogenous
ligands, suggests that the xenobiotic receptors also have functions in regulating the homeostasis of
endobiotics and impacting pathophysiology. Our overarching hypothesis is that xenobiotic receptors are
critical environmental chemical-sensing transcriptional factors that mediate the environmental
chemical effects on human disease and morbidity. Mechanistically, xenobiotic receptors impact the
pathogenesis of human diseases by regulating the metabolism of xenobiotics and endobiotics in both
the hepatic and extrahepatic tissues. We propose that the xenobiotic receptors are pivotal environmental
modifiers that integrate signals from chemical exposures to the regulation of many aspects of human
physiology. To test our hypothesis, we will assemble a highly experienced team and employ a broad spectrum
of genetic and pharmacological tools, transdisciplinary approaches, and the expertise of an array of
collaborators and clinician scientists to comprehensively define the roles that xenobiotic receptors play in
environmentally influenced diseases, such as fibrosis, metabolic syndrome, alcoholic liver disease, and
neurologic disorders. By understanding these pathways, we cannot only understand the environment-gene
interactions and the implications of these interactions in human diseases, but also establish xenobiotic
receptors and their target enzymes and transporters as potential therapeutic targets to manage these human
diseases and morbidity. The insights gained from this R35 program can be used to design intervention
strategies to manipulate these pathways via therapeutics or to guide human behavior or the human
environment in a manner that is most beneficial to the sensitive populations. Over the next eight years, this
R35 program will give us the freedom and power to make considerable advances in our understanding of
xenobiotic receptors and how they influence human health. As the Principal Investigator, I am committed to
devote 55% of my total effort to this R35 program, and all of my existing NIEHS funding will be consolidated
into this grant if funded. I am confident that I can lead this R35 program, because I have studied xenobiotic
receptors for two decades and have demonstrated a broad vision and made seminal contributions to our
understanding of the toxicological and pathophysiological functions of xenobiotic receptors.

Public health relevance
Title: Xenobiotic Receptors in Mediating the Environmental Effects on Human Disease and Morbidity Project Narrative The goal of this R35 program is to fill the gap between the exposure to environmental chemicals and the pathogenesis of human diseases. Through their ability to sense and be activated by environmental chemicals, xenobiotic receptors, such as PXR, CAR and AhR, are critical mediators for the environment-gene interactions. The outcome of xenobiotic receptor-mediated gene regulation is impacting the metabolism of xenobiotics and endobiotics and by doing so, impacting the pathogenesis of human diseases. Results from this R35 program cannot only deepen our understanding of the environment-gene interaction and the implications of this interaction in human diseases, but also establish xenobiotic receptors and their target xenobiotic enzymes and transporters as potential therapeutic targets to manage human diseases and morbidity. The insights gained from this R35 program can also be used to design intervention strategies to manipulate these pathways via therapeutics or to guide human behavior or the human environment in a manner that is most beneficial to the sensitive populations.